Mechano-Electrical Regulation of Neurogenesis

SUMMARY
Dysregulation of neurogenesis during brain development can impact neuron numbers, subtypes, and
connectivity, leading to a range of neurodevelopmental disorders. Our understanding of neuronal differentiation
is still limited, largely centered on growth factors, morphogens, and lineage-specific transcription factors, while
other fundamental aspects of cell biology such as plasma membrane properties and cytoskeleton mechanics are
overlooked. Emerging evidence reveals a critical role of membrane-related electrical processes in regulating
non-excitable cells such as neuroprogenitor cells (NPC) during corticogenesis. This R21 proposal explores the
previously under-studied inner membrane surface charge as critical regulator of morphological transformation
and neuronal lineage commitment. It is well known that anionic phospholipids are distributed asymmetrically
between the inner and outer leaflets of the plasma membrane. This is maintained by an ATP-dependent process
that leads to an overall negative surface charge of the inner membrane, known as zeta potential. This local
potential is different from the Nernst potential, a more global electrophysiological transmembrane potential
generated by diffusible ions. While the Nernst potential is well characterized in excitable cells such as neurons,
the inner leaflet surface charge and the associated mechano-electrical coupling is under-studied. The
asymmetric distribution of phosphatidylserine (PS) and phosphatidylinositol 4,5-bisphosphate (PIP2) in the inner
leaflet can influence plasma membrane stability via cytoskeletal interactions; they also serve as signaling hubs
for many downstream effectors. Our recent study revealed that NPC stiffness and cortical actin network can
affect the timing of neuronal differentiation. Reducing cell stiffness and cortical actin can accelerate neuronal
differentiation, likely through altered membrane surface charge, thus highlighting a novel link between mechano-
electrical coupling at plasma membrane and neuronal differentiation. Here, we will test the central hypothesis
that regulation of the inner membrane surface charge is critical during neurogenesis by affecting the organization
of cortical actin and signaling cascades associated with membrane phospholipids. In Aim 1, we will use live-cell
imaging, advanced fluorescent probes, and patch-clamp recordings to characterize the temporal and spatial
distribution of inner leaflet surface charges, phospholipid composition, and cortical actin rearrangement in
correspondence to morphological transformation during neurite outgrowth and neuronal differentiation. In Aim
2, we will manipulate membrane surface charge using our newly developed molecular actuators (ACTU- or
ACTU+) to either increase or decrease the negative charge at the inner membrane surface and assess the impact
on neuronal differentiation, maturation, survival, and functionality. In summary, this R21 proposal explores
mechano-electrical regulation of neurogenesis, which will provide insights into neurodevelopmental disorders
and improve disease modeling.

Public health relevance
PROJECT NARRATIVE Dysfunction of neuroprogenitor cells during brain development can lead to neurodevelopmental disorders. Our understanding of neurogenesis remains limited, mostly centered on lineage-specific transcription factors while other fundamental aspects of cell biology such as plasma membrane properties and cytoskeleton mechanics are overlooked. This R21 proposal explores previously under-appreciated surface charge of the inner leaflet of plasma membrane as signaling hub and organizer of cortical actin, thereby affecting neuronal lineage commitment.